Physiologically relevant cardiac tissue culture model for drug testing and disease modeling

Human tissue modelling in culture is a major challenge for drug discovery and screening, and disease modeling.
The ideal cardiac tissue culture model (CTCM) should accurately recreate the critical organ-level structure and
function. The success of CTCM depends on ability to mimic what occurs in the human body in physiological and
pathophysiological conditions. The heart is a unique organ that is subject to continuous cycles of alternating
pressure and stretch due to hemodynamic loading and unloading. These hemodynamic stressors are of critical
importance to cardiac function and metabolism in health and disease. Changes in stress within physiologic range
result in physiological remodeling, whereas significant changes (e.g., hypertension, ischemia, valve disease)
result in adverse pathological remodeling leading to cardiovascular dysfunction. We recently developed a system
to culture 300µM thick human heart slices that fully maintains their functionality for over 12 days through providing
the precise-cardiac-cycle hemodynamic pressures, stresses and electrical stimulation. This technology provides
access to complete 3D multicellular system that is highly similar to human heart tissue and emulates
physiological or pathological conditions, both functionally and structurally. Within our CTCM, we can control
electrical stimulation (current amplitude and frequency) as well as the critical mechanical parameters including
preload, afterload, pressures, rate of pressure change, and heart rate (HR) to accurately model normal and
pathological diseased conditions.
We hypothesize that establishment of physiologically relevant Human cardiac Tissue Culture Model needs
continuous functional monitoring of the human heart tissue that undergo a replication of all in vivo–like structural
and functional adaptation during health and disease. Through continuous monitoring of any changes on cardiac
function, this system will be able to accurately assess drug toxicity and efficacy in healthy and diseased cardiac
tissue. We will validate To test this hypothesis, we propose the following aims:
Specific Aim 1: (a) Incorporation of real-time monitoring of contractile force, strain, and
electrophysiological properties in culture for 12 days, and (b) validate the CTCM with real-time
monitoring to accurately predict drug cardiotoxicity (12 cardiotoxins. Specific Aim 2: Modeling cardiac
pathology using CTCM and testing for testing drug efficacy.
Successful completion of this project will validate our CTCM system and fulfill a significant need by the
pharmaceutical industry and regulatory bodies for a medium throughput, tissue culture technology that faithfully
replicates the human cellular and pathophysiology and is highly sensitive for cardiotoxicity responses to drugs
for drug discovery and screening. Such a system will enable better mechanistic understanding of heart failure
therapies, minimize drug related adverse effects in patients and enable faster, and more cost-effective drug
development and screening and enhance the confidence in a candidate drug by regulatory bodies (eg. FDA).

Public health relevance
Project Narrative There is a critical need by the pharmaceutical industry and regulatory bodies for a medium throughput, tissue culture technology that faithfully replicates the human cellular and pathophysiology and is highly sensitive for cardiotoxicity and efficacy responses to drugs, as this will optimize drug discovery and selection prior to undertaking costly and time consuming ‘first in man’ trials. To fulfill this need, we propose to develop and validate a new human heart slice culture system with continuous monitoring of cardiac function parameters that can accurately model normal and diseases states and precisely predict drug efficacy and toxicity. Our tissue culture system will be the first physiologically relevant, medium-throughput, cost-effective human heart system in culture.